DP22-001 Evaluating Real-world Diabetes Prevention Programs in a Multi-campus University System and a Three-state Regional Health Network

Project Summary/Abstract
In an innovative scientific partnership between researchers, the UC Office of the President (UCOP), and
Intermountain Healthcare, we will leverage existing electronic health record (EHR), insurance claims and
DPP cohort data to examine the long-term effectiveness and cost-effectiveness of the Diabetes Prevention
Program (DPP), as well as barriers and facilitators of participation in DPP in real-world settings. We
proposed a rigorous evaluation using diverse data sources from the University of California (UC), which is a
multi-campus university system and one of the largest employers in the State of California, and
Intermountain Healthcare, which is a three-state regional health network. We will create a merged multi-
ethnic and geographically diverse electronic cohort of adults at-risk of developing type 2 diabetes who
enrolled in DPP and propensity-matched controls who did not enroll in DPP. We will include all DPP delivery
models that have been in existence for nearly a decade in both systems. To assess the effectiveness of
real-world DPP delivery, we will examine percent weight change at 5-years follow-up among adults at risk
for developing type 2 diabetes, comparing those who completed DPP with those who did not enroll, and
also comparing those who started but did not complete DPP with those who did not enroll (primary
outcome). Secondary outcomes will examine changes in cardiovascular risk factors (e.g., blood pressure,
tobacco use), rates of incident type 2 diabetes and diabetes-related healthcare service utilization and
related costs. To assess the cost-effectiveness of real-world DPP delivery, we will estimate cost per case of
type 2 diabetes prevented and cost per quality-adjusted life years (QALYs) gained at 5-years follow-up. We
will also examine whether long-term effectiveness and cost-effectiveness vary by several factors, including
DPP entry criteria (e.g., blood test vs. risk test), program delivery mode, social determinants of health, age
group, or race and ethnicity. To examine barriers and facilitators to DPP participation, we will survey a
representative subset of DPP participants and non-participants. We will leverage our team's expertise in
DPP evaluation and track record of collaboration, and we will work closely with the coordinating center to
carry out this comprehensive multi-site evaluation study. Findings from this study will inform future UC
System and Intermountain Healthcare strategies addressing obesity and type 2 diabetes prevention, as well
as dissemination of effective strategies to other large university systems, healthcare systems and
employers.

Public health relevance
Project Narrative This project will examine the long-term effectiveness and cost effectiveness of DPP, as well as barriers and facilitators to DPP participation, among adults at-risk for developing type 2 diabetes in a Multi-campus University System and a Three-state Regional Health Network.